Investigating the Roles of Patient Beliefs, and Physician Communication on Disparities in Lung Cancer Screening

PROJECT SUMMARY
Lung cancer is particularly aggressive, lethal, and disparaged by its strong association with cigarette smoking, with a 5-year survival rate <15%. The burden of lung cancer in the United States falls disproportionally on Black individuals. Blacks have the highest incidence of lung cancer and both Black and Hispanic patients have worse outcomes than their white counterparts. Lung cancer screening, consisting of an annual low-dose computed tomography (LDCT) scan, is currently recommended by the United States Preventive Services Task Force to the 8 million smokers who are at high risk of developing lung cancer, and is poised to substantially reduce lung cancer deaths. Alarmingly, emerging national data demonstrates that only 3% of black eligible smokers received screening compared to 12% of white smokers in 2017. Prior research on cancer disparities fails to address issues that are specific to lung cancer (smoking shame, high mortality, and fatalism) and LDCT screening (new test, increased radiation exposure) and greatly limits the generalizability of the findings from these studies to lung cancer screening. In this project, we plan to assess modifiable health beliefs as well as smoking shame and medical mistrust that may influence lung cancer screening use. Given the newness and unique challenges of lung cancer screening, efforts to accurately identify barriers to LDCT screening early in its adoption are imperative to achieving an early correction to this disparity. The Specific Aims of the study are to: 1) Assess racial and ethnic differences in beliefs about lung cancer and LDCT screening and their association with lower rates of agreement to undergo screening and LDCT completion; and 2) Evaluate if racial and ethnic differences in smoking shame and medical mistrust are associated with lower rates of agreement to undergo screening and LDCT completion and underlie screening disparities. To achieve these aims, we will recruit lung cancer screening-eligible smokers and their primary care providers from a vast network of primary care practices in New York City. We plan to measure patient’s beliefs about lung cancer and LDCT screening, smoking shame, and medical mistrust and test associations with lung cancer screening referral and completion. The results of the study will directly guide the development of targeted strategies to improve lung cancer screening rates.

Public health relevance
Public Health Relevance Section Lung cancer screening is poised to substantially reduce lung cancer deaths, however there is evidence of racial disparities in its use. The objective of this project is to investigate the role of patient beliefs and medical mistrust, as well as physician communication on racial disparities in lung cancer screening referral and completion. We will conduct this study in a sample of Black and Hispanic smokers in a large primary care network in New York City.